Regulation of epithelial junctions stability and turnover by the RhoG exchange factor SGEF

PROJECT SUMMARY
Epithelial cells form tightly packed sheets of uniformly polarized cells, with an apical membrane
contacting the environment, lateral membranes held together by specialized cell–cell junctions, and basal
membranes anchored to other cells or the extracellular matrix. The establishment of apicobasal polarity in
epithelial cells is coordinated by three highly conserved protein complexes: PAR, Crumbs, and Scribble. These
polarity complexes contain proteins that act as scaffolds to recruit other binding partners, including the Rho
GTPases, to build spatially distinct signaling complexes. A major barrier to understand the formation of the
epithelium is our poor understanding of the mechanisms that control the function of the Scribble complex. For
over two decades, the Scribble complex was known to function as a module from genetic studies, but it was
unclear how the members of the complex interacted with each other, and their link to the regulators of adhesion
and polarity. To close this gap, my lab is focused in defining the precise composition, mechanism of formation
and regulation of the Scribble complex. We have recently shown that SGEF, a RhoG-specific GEF, is a new
component of the Scribble complex that acts as a scaffold to form a ternary complex by interacting directly with
Scribble and Dlg1, and plays a role during junction formation, and E-cadherin stability. Based on these findings,
the objective of this proposal is to define the molecular mechanisms that regulate the function of the
Scribble/SGEF/Dlg1 complex during cell-cell junctions’ assembly, maintenance, and turnover. We will test the
central hypothesis that the Scribble complex targets SGEF to the basolateral membrane where it regulates the
E-cadherin stability and endocytosis in a catalytic dependent manner. We propose the following specific aims to
test this hypothesis. Aim 1. Characterize the spatiotemporal regulation of SGEF-mediated RhoG activation by
the Scribble complex. Here we will test our working hypothesis that binding to Scribble and Dlg1 targets and/or
activates SGEF to cell junctions, which promotes the localized activation of RhoG, which is essential for the
regulation of E-cadherin expression levels; Aim 2. Define the role of the SGEF complex in the regulation of E-
cadherin stability and endocytosis. Our working hypothesis is that SGEF is recruited to the basolateral membrane
through its interaction with Scribble and Dlg1, where it regulates the stability of E-cadherin at the plasma
membrane.
This approach is innovative, as it provides mechanistic insight on a new function for the Scribble complex.
This contribution will be significant because it will shed light on the fundamental mechanisms controlling cell-cell
adhesion and its role in the establishment of polarity in epithelial cells and tissues. Understanding how cell
adhesion and polarity are established and maintained in normal cells is important for situations in which loss of
adhesion and polarity represent a problem, such as epithelial cancers, which comprise 85% of all human
cancers.

Public health relevance
PROJECT NARRATIVE Most internal organs consist of a monolayer of polarized epithelial cells surrounding a central lumen, which functions to establish a barrier that segregates the internal medium from the outside environment in tissues and organs. This proposal will uncover the fundamental mechanisms controlling the function of a novel protein complex that coordinates junctional assembly, stability, and turnover in epithelial cells. Understanding the molecular mechanisms of these fundamental processes, which are essential for tissue morphogenesis and organ development, is a major obstacle in our quest to develop therapies treat or prevent epithelial cancers, which are mostly from epithelial origin.